Targeted MDM2 degradation for improved treatment for triple-negative breast cancer

Although significant progress in targeted and immunotherapies has been made in recent years, effective
treatment of TNBC remains a challenge. Clinical studies of TNBC tumors have revealed that the overexpression
of the oncogene MDM2 are positively associated with tumor stages and are an independent negative prognostic
factor for TNBC patients, indicating that target MDM2 is a promising strategy for improved TNBC treatment.
However, existing MDM2 inhibitors such as AMG-232 (KRT-232) only block the MDM2-p53 binding, dependent
on wild-type p53 activation for their anticancer activity and with a risk of increasing MDM2 expression due to the
p53-MDM2 negative feedback loop. Distinct from this mechanism, we recently discovered a novel class of MDM2
degraders binding to the MDM2 RING domain, with CH175 as the current lead compound, that induces tumor
regressions in clinically relevant TNBC PDX models. Based on these preliminary studies, our central
hypothesis is that the CH175 scaffold as a first-in-class MDM2 degrader can be further optimized, leading to a
potential future clinical candidate for improved therapy outcomes in TNBC patients.
Aim 1: Perform focused structure-based optimization of the CH175 scaffold to develop new analogs
with increased binding to the MDM2 RING domain and increased anti-TNBC potency. Aim 1.1. Perform
focused optimization of the CH175 scaffold to increase their binding to the MDM2 RING domain and drug-like
properties. Aim 1.2. Screen new CH175 analogs using a panel of TNBC cell lines. Aim 1.3. Screen the selected
CH175 analogs for their drug-like properties, and assess potential off-target effects for the selected analogs.
Aim 2: Elucidate the molecular mechanisms by which CH175 and new analogs degrade MDM2,
leading to strong anti-TNBC activity. Aim 2.1. Confirm CH175-MDM2 RING-domain binding, effects on E2,
E3 ligase activity, and association with improved anti-TNBC activity. Aim 2.2. Demonstrate that the MDM2 is a
critical target for CH175 and its best analogs. Aim 2.3. Demonstrate biological effects of CH175 and analogs on
MDM2 downstream pathways using in vitro and in vivo biochemical and molecular biology technologies.
Aim 3: Demonstrate in vivo efficacy and characterize the pharmacological and toxicological
properties of CH175 and up to two best new analogs using clinically relevant TNBC PDX models. Aim
3.1. Determine Maximum Tolerance Dose (MTD) and Minimal effective concentration (MEC). Aim 3.2. Perform
PK/PD correlation study to demonstrate the in vivo drug behavior and MDM2 targeting efficacy. Aim 3.3.
Demonstrate in vivo efficacy in comparison with clinically used drugs and the best available MDM2 inhibitors.
Aim 3.4. Perform initial in vitro and in vivo non-GLP toxicity screening following FDA guidelines.
Impact: Existing MDM2 inhibitors depend on disrupting the MDM2-p53 binding and have not resulted in
positive outcomes in clinical trials. The CH175 scaffold as a first-in-class MDM2 degrader has anticancer activity,
regardless of p53 status. If successful, a novel MDM2 targeted therapy will be developed for TNBC treatment.

Public health relevance
Project Narrative There is an unmet medical need to develop more effective therapies for triple-negative breast cancer (TNBC). The overexpression of the oncogene MDM2 is positively correlated with TNBC disease progression/metastasis and poor patient survival. In this project, we propose to optimize a newly discovered scaffold that works as MDM2 degraders in TNBC models, confirm their mechanisms of action, and comprehensively determine their preclinical efficacies in TNBC mouse models, with the ultimate goal of developing a targeted therapy for improved TNBC treatment.